Biospecimens and Cell Models Core

PROJECT SUMMARY
The overall goal of the Biospecimens and Cell Models Core is to provide human biospecimens for biomarker
discovery for early ADPKD progression, offer an assortment of biomaterials from human ADPKD and normal
kidneys for translational research, and assist investigators with in vitro PKD assays to test hypotheses and
evaluate potential therapeutic targets. The Core will maintain and expand the PKD biospecimen repository of
sera, plasma, peripheral blood mononuclear cells (PBMCs), urine, and urinary extracellular vesicles (exosomes)
from the multi-center longitudinal Early PKD Observational Cohort (EPOC) study of children and young adults
with early ADPKD. In addition, the Core will bank biospecimens obtained from undiagnosed siblings of the
ADPKD patients, and unaffected siblings and normal healthy volunteers that will serve as control subjects. The
Core will also maintain a repository of frozen freshly obtained tissues, formalin-fixed paraffin-embedded tissues,
cyst fluids, primary cultures of ADPKD cyst epithelial cells, sera, plasma, urine, and urinary extracellular vesicles
(exosomes), obtained from ADPKD patients at the time of nephrectomy. The aims of the proposal are (1) To
provide human biospecimens, including sera, plasma, PBMCs, urine, and urinary exosomes, from children and
young adults with ADPKD and normal controls for biomarker discovery. (2) To provide human biomaterials,
including frozen and fixed tissues, cyst fluids, DNA, RNA, and primary cells from ADPKD and normal human
kidneys, and (3) To assist investigators with in vitro PKD assays.